Sequential Reading Effects in Digital Breast Tomosynthesis

Project Summary/Abstract
Digital breast tomosynthesis (DBT) has emerged as a viable imaging modality for breast cancer
screening. But despite its improvements over standard mammography, the breast imaging community is
well aware of its limitations. Roughly 40 million women in the United States have a screening mammogram
each year, and the combination of a high-volume exam and less than ideal performance have made
screening mammography an active area of research for many years.
Prior studies have shown that reading breast screening images in batches improves performance, in
terms of lower overall recall rates without significant change in the cancer detection rate. But no
mechanism for this improvement has been demonstrated. A recently published clinical trial in the UK with
over 1 million screening mammograms read by 360 practicing clinicians finds that screening performance
actually improves as a reader progresses through a batch of mammograms. We hypothesize that, rather
than vigilance, the operational mechanism affecting performance in batch reading is adaptation, which is
consistent with improved performance over the course of a batch.
We propose to characterize sequential reading effects in DBT images, to see if there is evidence to
support our hypothesis that readers visually adapt to the statistical structure of the images as they read
them. A few studies have shown adaptation effects in digital mammograms, but there have been no studies
to date evaluating sequential effects in DBT. If adaptation is functioning in batch reading of DBT images,
then there are a variety of was to take advantage of it to improve screening performance.
We propose a thorough evaluation of sequential effects in DBT images that includes basic visual
assessments of adaptation, statistical analysis of retrospective clinical data, and prospective analysis of
performance in clinical reader studies. These will be analyzed to determine if image readers are consistent
with the adaptation hypothesis, improved performance with depth in a batch, and modeled to see if there
are additional factors that influence adaptation.
Our project consists of three specific aims that cover these topics. Aim 1 implements a battery of
visual assessments that define and characterize visual adaptation to DBT images. Aim 2 proposes mining
clinical DBT reading data at the University of Pittsburgh Medical Center to evaluate retrospective
performance detecting cancer (true-positive rates) and recalling patients (false-positive rates). This data
will be modeled with factors that include adaptive sequential effects. Aim 3 will evaluate screening
performance in DBT images in “laboratory” studies using clinical readers and cases that evaluate the effects
of different batch length and the ordering of cases within a batch.

Public health relevance
Project Narrative for “Sequential reading effects in digital tomosynthesis” As digital breast tomosynthesis imaging starts to be used for a more substantial portion of breast- cancer screening, it is important that the reading environment support the highest achievable diagnostic performance. We hypothesize that high-level visual adaptation may be an important mechanism for improved performance in batch reading of these images. Our study is designed to characterize the adaptive effects of these images using basic visual assessments, analysis of clinical reading data, and observer performance studies.